Biomarker-Driven Strategies to Overcome Immunotherapy Resistance in STK11-Deficient NSCLC

SUMMARY
Despite significant advances in Immuno-Oncology (IO) treatments, lung cancers with loss-of-function
mutations in STK11, comprising 20-30% of cases, demonstrate poor prognosis due to resistance to these
strategies. Our proposal targets the interaction between specific tumor 'differentiation phenotypes' and immune
resistance pathways, associated with STK11-Deficient lung cancers. Firstly, we've found that these
differentiation phenotypes drastically influence the immune composition of the tumor microenvironment (TME)
and the patient's response to immune checkpoint blockade (ICB). Furthermore, we've developed STK11-MLDD,
a novel biomarker that measures these differentiation phenotypes and may predict ICB benefit. Secondly, we've
identified the immune regulator TRAF2 and its partner cIAP1 as promoters of immune resistance, specifically in
the context of STK11 deficiency, and appear to be linked to the neuroendocrine differentiation phenotype. These
findings provide the foundation for our two complementary aims.
Aim 1 focuses on characterizing the interaction between tumor differentiation phenotypes, corresponding
immune TME phenotypes, and clinical response to ICB. We'll validate the STK11-MLDD biomarker in multiple
patient cohorts and develop it as a clinical tool for future trials. Additionally, using flow cytometry and single cell
RNAseq data, we will identify specific suppressive immune cell populations and resistance phenotypes in the
TME associated with different STK11-MLDD differentiation subsets. Aim 2 centers on understanding
TRAF2/cIAP1-mediated immune evasion and validating TRAF2 as a potential clinical target in lung cancer. We'll
conduct experiments evaluating changes in TNF signaling resulting from STK11 loss and TRAF2/cIAP1,
assessing their impact on anti-tumor immunity. Additionally, we will conduct in vivo experiments to examine
STK11-/TRAF2-mediated effects on the TME and the potential for TRAF2 inhibition to enhance ICB response.
We anticipate that our results will establish TRAF2/cIAP1 inhibition as a promising clinical target for STK11-
deficient lung cancer, while also defining novel mechanisms of immune resistance and additional precision
treatment candidates for these cancers. Furthermore, the STK11-MLDD biomarker is expected to have use not
only as a clinical predictor of ICB response, but also potentially as a ‘treatment-selective’ biomarker that could
be used to identify patients likely to respond to precision approaches such as cIAP1 inhibition.
As a physician-scientist in thoracic oncology, my career goal is to become a successful independent
academic investigator, focusing on STK11-mutated NSCLC to improve treatments and outcomes for patients
with these cancers. We have outlined a detailed mentorship and career development plan that will complement
my scientific approaches and promote mastery of skills necessary for my long-term success, with specific focus
in the areas of 1) bioinformatics and biostatistics, 2) tumor immunology and immune oncology, 3) academic
leadership. Achieving these goals will accelerate my success and maximize my long-term impact in the field.

Public health relevance
NARRATIVE Loss-of-function alterations in STK11 have been shown to confer poor prognosis and resistance to immune checkpoint blockade (ICB) in NSCLC through incompletely understood mechanisms of tumor intrinsic resistance and immunosuppressive features of the tumor microenvironment (TME). Here, we propose investigation of tumor differentiation phenotypes as a key determinant of immune resistance, and parallel evaluation of TRAF2/cIAP1 as a critical and targetable resistance mechanism that appears to be influenced by differentiation state. Our work will combine in vitro mechanistic studies, in vivo and patient level studies of TME and ICB response, and development of differentiation-based biomarker that can accurately detect these phenotypes in clinical samples. Our results will establish TRAF2/cIAP1 inhibition as a promising target to enhance immunotherapy response in STK11-deficient lung cancer, alongside a paired biomarker that may guide the clinical use of this approach, thus representing a novel precision IO paradigm.